Core A: Administration Core

Core A: Administration Project Summary
The Administration Core acts to ensure that the research and programmatic goals of the Healthy Aging and
Senile Dementia Program Project grant (HASD PPG) are met. The administrative leadership consists of the
Director (Morris), Associate Director (Holtzman), and Executive Director (Moulder). They are assisted by the
Leadership Committee that includes these individuals, leaders of Cores and Projects, and other senior faculty.
The Administration Core supports, monitors, and coordinates the activities of all components of the HASD
PPG. It will annually convene an External Advisory Committee to review activities and progress. The specific
aims are to:
1) Coordinate and integrate all Cores and Projects and monitor the effectiveness of the PPG toward
achieving the stated goals.
2) Provide administrative and budgetary support and oversight to the Cores and Projects, ensuring
appropriate utilization of the funds in all PPG activities.
3) Arrange for periodic external review and advice regarding PPG goals and programs.
4) Provide oversight and administrative support for data integration with Core C: Biostatistics to maintain and
monitor an integrated database for the PPG.
5) Facilitate inclusion of HASD participants and data in other local (AD research at Washington University)
and national AD initiatives, including the Alzheimer's Disease Neuroimaging Initiative (ADNI), the Alzheimer's
Disease Genetics Consortium (ADGC), the National Institute on Aging Genetics of Alzheimer's Disease Data
Storage Site (NIAGADS), trials orchestrated by the Alzheimer's Therapeutic Research Institute (ATRI) and the
new Alzheimer Clinical Trials Consortium (ACTC), and the National Alzheimer Coordinating Center (NACC).

Public health relevance
Core A: Administration Project Narrative The Administration Core ensures that the goals of the Healthy Aging and Senile Dementia (HASD) program Project Grant are met, namely identifying indicators that signal the progression from cognitive normality to cognitive impairment caused by AD. With the assistance of an External Advisory Committee and a Leadership Committee including the Leaders of the Projects and Cores, the Administration Core supports, monitors, and coordinates all activities of HASD.